DEVELOPMENT OF INTESTINAL TRANSPORT OF CA++ AND PI

Rickets of prematurity is a common clinical entity occurring in 30 percent of infants born weighing less than 2000 gm. The cause of this entity is not known. Alteration in vitamin D metabolism and/or calcium and phosphate intake or transport have all been propsed as etiological factors. Our lack of understanding of this entity at least in part, stems from lack of basic knowledge of intestinal transport of calcium (Ca) and phosphate (Pi) and their relationship to vitamin D during early development. Because of the many functional similarities between the suckling rat intestine and premature infant intestine, the principal investigator has used suckling and weanling rats as models for studying the maturational aspects of intestinal transport of minerals. Studies using in vivo perfusion and in vitro everted gut sacs, suggested that intestinal Ca transport shows a maturational phenomena with predominately passive process in the suckling period which evolves to an active process by weaning. Recently, the use of isolated membrane vesicles from adult rat intestine enabled an in-depth study of the transport of sugars and amino acids. We have validataed the use of the membrane vesicles for the study of transport during suckling and weanling periods in the rat. Using this methodology, we propose a detailed examination of subcellular processes of Ca++ and Pi transport during early life. The methods of procedure involve a sequential breakdown of the small intestine from in vivo and in vitro experiments done previously to progressively small functional components involved in transcellular Ca++ and Pi transport. The proposal is designed to study: (1) The process by which Ca++ and Pi enter into the intestinal epithelial brush border membrane; (2) The process by which Ca++ and Pi exit at the basolateral membrane; (3) The role of 1-25 (OH)2 vitamin D3 in these two processes during early development. Since in vivo studies suggested an important maturational effect, these processes will be examined in an animal model during maturation (i.e., suckling and weanling rats). The effects of vitamin D will be evaluated in offspring of deficient mothers, vitamin D deficient rats treated with 1-25 (OH)2 D3 and in vitamin D sufficient controls during the suckling and weanling periods; and (4) Because the maturational changes in transport may be the results of changes in membranes, the composition of brush border and basolateral membranes in the suckling and weanling periods will be determined.